EXPLANATORY MODEL OF ASTHMA

The interview guide has been developed and pilot tests have been completed on one subject. Three additional subjects are scheduled to complete interviews and one interview has been transcribed. A change in recruitment strategy has taken place in order to facilitate recruitment and interviews.